Chemotactic Cytokines Gordon Research Conference and Seminar

PROJECT SUMMARY:
The chemokine system consists of chemokines, their cognate G-protein coupled receptors and their
atypical receptors, which are structurally related but do not couple to G-proteins. It is an unusually
diverse and promiscuous network involved in almost every physiological process of jawed vertebrates.
The complexity requires studying the system from different viewpoints and with different tools,
approaches and techniques. A prominent feature of the chemokine system is to guide cell migration and
position cells in specific niches. The 2022 Gordon Research Conference (GRC) on Chemotactic
Cytokines: "Orchestrating cell migration and localization in health and disease" is an internationally
renowned meeting dedicated to deconvolute the mechanisms and unveil new functions of the
chemokine system. This will be the 14th edition of the Chemokine GRC, which has been held every other
year since 1994 (except for 2020), when chemokines first emerged as the largest cytokine gene family
in the human genome. As in the past, the Chemotactic Cytokine GRC 2022 will attract scientists from
diverse biomedical disciplines to discuss the latest unpublished results that will tackle many aspects of
chemokine-related research. The proposed program calls on outstanding specialist that will present new
findings, new concepts and potential implications, including translational perspectives. Hence, the
meeting will cover basic biochemical and biological aspects of chemokines related to their contributions
to cell migration, immune function, and their role in inflammation, infection, autoimmunity and cancer.
New developments in potential drugs and disease treatment strategies will also be discussed. The GRC
will, like at the recent four editions, be accompanied by a satellite Gordon Research Seminar (GRS) on
Chemotactic Cytokines. The GRS "Exploring the chemokine system: from structures to functions" is
particularly designed for young scientists, graduate students and early postdocs. These next generation
scientists will present their work and receive feedback on their research projects from their peers and
from a selected panel of senior internationally renowned field experts and at the same time the forum
will promote integration and networking within the field of chemokine research. NIH funding is requested
to provide partial support for registration of the participants. We fully anticipate that the scientific
discussions, research talks, poster sessions, and informal interactions between the participants of this
conference will contribute to advancing our understanding of molecular mechanisms of chemokine
involvement in health and disease. The conference will foster the development of new collaborative
projects, which will lead to new discoveries and ultimately new therapies and approaches to treat
debilitating human pathologies, including inflammatory, autoimmune, infectious diseases and cancer.

Public health relevance
PROJECT NARRATIVE: The Gordon Research Conference and the Gordon Research Seminar on Chemotactic Cytokines will bring together scientists from all over the world from an unusually diverse array of scientific disciplines to discuss the functions of chemokines in health and disease ranging from inflammatory diseases to cancer and autoimmunity. It will pave the way for the identification of new therapeutic targets for drug development by fostering the exchange of information between basic scientists, clinicians and researchers from the biomed industry. After the pandemic-caused interruption the meeting will again promote direct informal exchange of ideas coming from different scientific disciplines, countries, as well as ethnic, experience and gender groups, and facilitate the training of the next generation scientists in this multidisciplinary research field.